Expecting Mothers' Study of Consumption or Avoidance of Peanut and Egg (ESCAPE)

PROJECT SUMMARY/ABSTRACT
Whereas peanut (PN) allergy is the most common cause of fatal and near-fatal food-allergic reactions in older
children and adults, egg and cow’s milk are the most common food triggers of anaphylaxis in infancy. Egg allergy
is the most common childhood IgE-mediated food allergy with prevalence rates ranging from 1.3-1.6% in general
population up to 20% in high-risk infants. Egg sensitization is a significant risk factor for PN allergy and early
aeroallergen sensitization, which can lead to the “atopic march”. Black children are over-represented among
children with egg allergy and asthma is more prevalent in children with allergy to egg than any other food. Only
50% develop tolerance to egg by school-age; PN allergy is rarely outgrown. There is a critical “window of
opportunity” for the introduction of allergenic solids around 4-6 months in decreasing the risk of food allergy as
shown in randomized controlled trials with egg and PN. However, 36% of infants were already sensitized to egg
at enrollment and about 9% to PN, excluding them from early introduction; 20% infants were clinically allergic,
even anaphylactic, on their first introduction of egg. To be more effective, primary prevention strategies must
begin much earlier before sensitization is established, possibly even during pregnancy or breastfeeding.
Prior studies are conflicting in the effect of maternal diet including or excluding egg or PN on development of
food allergy in infancy. Per the American Academy of Pediatrics, “Current evidence does not support a role for
maternal dietary restrictions during pregnancy or lactation”, but randomized controlled trials are lacking.
Thus, there is an urgent need to provide mothers with concrete advice on feeding practices based on good
quality evidence. The overall objective of this application is to define the role for egg and PN exposure during
pregnancy and via human milk in food sensitization and to identify the biomarkers of sensitization or tolerance.
We will conduct a nationally-enrolled, randomized controlled, four-arm parallel trial. Mothers pregnant with
infants at high risk (with first degree relative with an atopic disease) who intend to breastfeed >3 months will be
enrolled utilizing social media and referrals and randomized to either consumption or avoidance of egg and PN
containing foods throughout pregnancy and lactation to assess the risk of sensitization to egg and PN at 4
months before introduction of solid foods. In Aim 1, we will determine the effect of maternal dietary egg and PN
avoidance during pregnancy and lactation on the risk of egg and PN sensitization in high-risk infants. In Aim 2,
we will assess the level of infant oral and environmental exposure to egg and PN. In Aim 3, we will identify the
immune responses elicited by maternal diet including or excluding egg and PN during pregnancy and lactation.
Knowledge gained from these studies will uncover mechanisms of early-life sensitization necessary to establish
maternal dietary guidelines in prevention of food allergy and the atopic march.
1

Public health relevance
PROJECT NARRATIVE Prior studies are conflicting in the effect of maternal diet including or excluding egg and peanut on development of egg and peanut allergy in infancy, and randomized controlled trials are lacking. In this proposal, we will define the role for egg and peanut exposure during pregnancy, through human milk and house dust in food sensitization in infancy and identify the biomarkers leading to tolerance of sensitization. Knowledge gained from these studies will uncover mechanisms of early-life sensitization necessary to establish maternal dietary guidelines in prevention of food allergy and the atopic march.